Telemedicine for Pediatric Sickle Cell Care in Medically Underserved Communities

Sickle cell disease (SCD) is the most common inherited hematologic disease. Studies have shown that
comprehensive medical care can decrease adverse outcomes associated with SCD, but such care is not
easily accessed. It is estimated that less than 70% of children with SCD receive comprehensive care, and only
20% experience effective care coordination. Additionally, comprehensive sickle cell centers are most
commonly located in major metropolitan areas, making it difficult for families in rural or medically underserved
areas to access comprehensive care. Telemedicine, the remote provision of medical care using modern
information technology, is a potential strategy to address the barriers experienced by patients with SCD
living in rural and medically underserved areas. Not only have studies demonstrated that telemedicine is
safe and effective, but the current SARS-CoV2 pandemic has shown how it can increase local access to
subspecialty care. My preliminary work in preparation for this resubmission demonstrated the feasibility
and acceptability of telemedicine for SCD care in a rural part of Indiana (AHRQ K12 HS026390). My long-
term goal is to improve access and adherence to quality care for children with SCD. The objective of this
application is to investigate the use of various telemedicine models to provide comprehensive care to
children with SCD in rural and medically underserved communities without ready access to specialized
services. We will use the results gathered from our preliminary K12 work to adapt, refine, and pilot an
existing hub-and-spoke model and a direct-to-consumer model. I hypothesize that both telemedicine
models will be a feasible means of providing evidence-based comprehensive pediatric SCD care to
patients in rural or medically underserved areas, with caregivers and patients having decreased barriers
to care and improved caregiver/patient-centered outcomes with the direct-to-consumer model. The specific
research aims of this proposal are: (1) Adapt two telemedicine models for use with children with SCD using
caregiver input from our preliminary K12 work; (2) Demonstrate the feasibility of the telemedicine models
developed in Aim 1 as they undergo successive stakeholder refinement during use in actual clinical care; (3)
Evaluate the effectiveness of the refined models from Aim 2 in a pre/post study by assessing (a) process of
care measures, (b) provider satisfaction, (c) caregiver/patient-centered outcomes, and (d) clinical outcomes
and healthcare utilization. I will apply for R21/R03 funding to scale-up the models to additional
communities statewide based on how each performs in different environments. I will also apply for R01
funding to assess, through a randomized controlled trial, their effect on health care utilization, disease
outcomes, and caregiver/patient-centered outcomes. This work can be adapted to evaluate the impact of
telemedicine on issues like hydroxyurea use and adherence. The proposed research will also help me
develop skills in patient-centered research methods as well as improvement and implementation science.

Public health relevance
Project Narrative Access to comprehensive pediatric sickle cell care continues to be a national concern, and is even a more pressing issue in rural and medically underserved areas. As telemedicine has been shown to be an effective means of providing care to pediatric populations living in rural and underserved areas, we propose to directly address barriers identified in previous work to the provision of comprehensive sickle cell care by adapting, refining, and piloting two telemedicine models (i.e., hub and spoke model and direct-to-consumer model). This research will not only expand access to comprehensive care for children with sickle cell disease, but our approach will help identify which telemedicine model is most appropriate for various environments, and we can easily adapt this approach for other subspecialty populations.